Defining cytoskeletal mechanisms driving cell motility in Naegleria

PROJECT SUMMARY/ABSTRACT
Although actin is highly conserved throughout eukarya, the mechanisms used to regulate its assembly and
disassembly vary across phyla. Precisely timed and placed actin assembly orchestrates nearly every cellular
process, including cell migration. While actin-driven cell migration has been defined in some detail in animal
cells, it is unknown if diverse eukaryotic pathogens operate using the same set of rules. This proposal will
address the hypothesis that there are conserved principles of cell migration by investigating Naegleria, which
diverged from the “yeast-to-human” lineage over a billion years ago. Specifically, this work will define the
contributions of the cytoskeleton to cell crawling in the “brain-eating amoeba” Naegleria fowleri: a pathogen
that crawls into and within the brain, causing a deadly form of meningitis for which there are no reliable
treatments. Dr. Velle’s initial postdoctoral research using the commonly-used, non-pathogenic model system
Naegleria gruberi highlights the potential for universal rules of motility; N. gruberi crawls on flat surfaces using
thin, actin- based protrusions assembled by proteins called the Arp2/3 complex. This actin and Arp2/3 based
mechanism is also how animal cells crawl on flat surfaces. However, outside of laboratory conditions, cells
rarely—if ever—crawl on flat, uniform surfaces. Animal cells are well-known to switch to a different mode of
motility when crawling through complex, restrictive environments, but this has not been tested in Naegleria.
Because N. fowleri crawl through narrow channels in the skull and into the brain, despite no known
chemotactic signals, dissecting cell migration in restrictive environments is essential for understanding disease.
Therefore, Aim 1 will determine mechanisms of cell crawling under confinement at the level of cell behavior.
Aim 2 will focus on the actin networks in cells; while the protrusions driving N. gruberi migration on flat surfaces
look similar to those of animal cells, defining the actin architecture using Platinum Replica Electron Microscopy
(PREM) will reveal if the ultrastructure is conserved. This aim will also provide critical training to complement
Dr. Velle’s background in light microscopy. The world expert in PREM, Dr. Svitkina, will provide this training as
a member of the scientific advisory committee. Aim 3 will use biochemistry—a technique the applicant has no
prior training in—to examine the upstream mechanisms of Arp2/3 complex activation. Dr. Velle has recruited
Dr. Bruce Goode, an expert actin biochemist, for this training. Because the leading labs in the field of cell
migration frequently employ both microscopy and in vitro actin biochemistry, the proposed training in PREM
and biochemistry will ensure the applicant is skilled in the techniques required for success. Dr. Velle has also
recruited Dr. Matt Welch, an actin expert, Dr. Meg Titus, who has expertise in actin and amoebae, and Dr. Jim
Morris, an expert in N. fowleri, to her scientific advisory committee to provide scientific and career mentoring.
Collectively, the proposed work will provide the technical training, and career mentorship required to launch Dr.
Velle’s career as an independent investigator with a research program focused on Naegleria’s migration.

Public health relevance
PROJECT NARRATIVE The “brain-eating amoeba” Naegleria fowleri can migrate through narrow channels in the skull and within brain tissue, causing a rare but often-fatal form of encephalitis. While cell migration has been described in extensive detail in animal cells, Naegleria diverged from this lineage over a billion years ago—before plant and animal lineages diverged—and it is therefore unknown whether mechanisms underlying animal cell motility are conserved in Naegleria. The goals of this application are to define the molecular basis of Naegleria’s cell migration in environments that mimic the brain, thereby providing a foundation to understand how Naegleria and similar pathogens cause disease.